A multi-centric randomized trial of daily nitrofurantoin versus bladder fulguration plus daily nitrofurantoin for the long-term management of cystitis in women with recurrent urinary tract infections

ABSTRACT
Urinary tract infections (UTIs) result in considerable morbidity and healthcare expenditures, especially for those
who suffer from recurrent UTIs (rUTIs), defined as 3 or more symptomatic UTIs in a 12-month period or 2 or
more in a 6-month period. Recent research has determined the considerable physical and psychological toll of
UTIs and our work has demonstrated the frequency and impacts of antibiotic resistance and allergy in patients
with rUTIs. Low-dose long-term antibiotic prophylaxis is one of the strategies typically considered for individuals
who have frequent UTIs and have not durably responded to several 5-7-day courses of antibiotics. To investigate
the source of reinfection in rUTI sufferers, our group examined the bladder wall during office cystoscopy and
observed evidence of chronic inflammatory changes over the trigone and bladder base. Using a simple outpatient
cystoscopic procedure, electrofulguration (EF), or cauterization of these areas of chronic inflammation within the
bladder, we have shown symptomatic relief, endoscopic resolution of cystitis lesions, and clinical reduction in
rUTIs. We recently reported long-term outcomes after EF (median follow-up 11 years) in women with stage 1
and 2 cystitis and a history of uncomplicated rUTI; 72% of women were cured, 22% were improved, and 6% did
not benefit from the procedure. Work with collaborators using 16S rRNA fluorescence in situ hybridization (FISH)
revealed resident intracellular/intratissue bacteria in inflamed regions of the bladder wallputative sources of
reinfection. Despite our promising results, large gaps in knowledge on the management of women with rUTI
indicate the need for definitive Level I evidence comparing the benefits of guideline-driven management relying
on long-term (6 months) daily antibiotic prophylaxis versus EF of areas of chronic cystitis combined with long-
term (6 months) daily antibiotic prophylaxis. Our central hypothesis is that those treated with EF will experience
superior reduction in UTI episodes compared to those undergoing the standard antibiotic therapy alone. Here,
we will perform a multicenter, randomized trial to determine whether EF with 6-month antibiotic prophylaxis will
reduce UTI episodes in the 1-year (Aim 1) and 2-year (Aim 3) follow-up compared to 6-month antibiotic
prophylaxis alone in women with a well-documented history of uncomplicated rUTI (Aim 1). We will determine
changes in the urinary microbiomes due to EF with 6-month antibiotic prophylaxis compared to 6-month antibiotic
prophylaxis alone (Aim 2). The multicenter, randomized clinical trial will enroll 104 women, aged 18 – 85, and
consistent with current guidelines, use nitrofurantoin for antibiotic prophylaxis, a preferred antibiotic for rUTI
treatment and prevention due to its concentration in the urine, low rates of resistance and allergy, and favorable
safety profile to treat cystitis alone.

Public health relevance
NARRATIVE Urinary tract infections (UTIs) result in over 8 million physician visits annually, an estimated cost of $4-5 billion, and considerable physical and psychological tolls, especially for those who suffer from recurrent UTIs (rUTIs). Electrofulguration, a procedure involving cauterization of inflamed areas of the bladder presumed to harbor bacteria causing these recurrent episodes, is emerging as a promising approach for the management of women with uncomplicated rUTIs. To rigorously test this approach, while at the same time respecting current rUTI treatment guidelines, we will perform a multicentric randomized clinical trial to assess the short-term (1-year) and longer-term (2-year) efficacy of antibiotic prophylaxis alone (standard of care) for 6 months compared to 6 months of antibiotic prophylaxis and electrofulguration.